Administrative Core

The goal of the CCII COBRE is to establish a thematic multidisciplinary research center of excellence at the
University of Louisville that focuses on improving our understanding of cancer immunology and developing
novel immunotherapeutic approaches. Importantly, with the recent clinical successes of immune checkpoint
inhibitors and oncolytic viruses, there is great interest and momentum in understanding the interaction between
the host immune system and neoplastic cells. Our projects proposing basic immunology research coupled with
translational and human specimen studies are expected to ultimately lead to entirely new immunotherapeutic
approaches, as well as strategies for overcoming resistance to existing agents. The Administrative Core (AC)
will coordinate the professional activities of the more than 40 individuals who will constitute the new Center for
Cancer Immunology and Immunotherapy (CCII). The AC will provide administrative, fiscal, and scientific
oversight and planning for junior investigators, mentors, projects, the research core, a pilot program, and
advisory committees. In addition to governance functions, the AC will provide key research and mentoring
support. This will include the awarding of project grants, assignment of mentors, provision of a grant writing
mentorship program, biostatistics and bioinformatics support, compliance and regulatory oversight, mentoring
of pilot projects, and encouragement of diversity and inclusion. Internal advisors and an External Advisory
Committee (EAC) that consists of five leading scientists in the CCII thematic area will guide the AC. The EAC
will provide scientific guidance and constructive feedback regarding center/project progress and be involved in
CCII strategic planning and in the selection of replacement and pilot projects. The two PIs of the overall CCII
program will direct the AC with key support from two co-Is who have extensive experience administering multi-
component grant programs and from two additional co-Is who are well qualified to oversee the essential
biostatistics and bioinformatics support. Their efforts will supplement a mentoring program that is anchored by
eight senior investigators who are experienced mentors and have been highly productive and well funded in
the thematic area. The three specific aims of this Administrative Core that encompass all of these functions are
to: (1) Establish procedures for CCII administration, planning, and decision-making; (2) Provide a mentorship
program to accelerate the careers of the CCII junior investigators; and (3) Create a CCII pilot grant program
that will stimulate new projects and collaborations. Innovative features of the AC are built on lessons learned
from establishing other multidisciplinary thematic centers and include a shared governance approach that aims
to ensure engagement of all participants and a holistic mentoring strategy that provides comprehensive
guidance for our CCII junior investigators. By the end of the 5-year funding program, we expect that 4-6 CCII
junior investigators will have been awarded R01 grants and that many of these graduates will remain key
members of this new COBRE focused on cancer immunology and immunotherapy.